Computational Psychiatry 2024 Conference

Project Summary
The purpose of this R13 conference grant is to seek partial funding support for the second
international Computational Psychiatry Conference. This meeting will be held over three days
(16-18 July 2024) in Minneapolis, Minnesota on the campus of the University of Minnesota,
providing a centralized location that is both accessible and compact, allowing for interactions
among attendees. The conference builds on a very successful first iteration held in Dublin,
Ireland in 2023, as well as a 6 year (2014-2019, 2022) successful workshop run out of
University College London and then Mount Sinai medical school.
The specific goal of the conference is to bring together early-career and established
investigators working on clinical and computational questions related to mental health and
addiction. Our aim is to build a productive and career-enhancing annual conference that
supports the development of researchers to translate neuroscience discoveries into psychiatric
clinical practice and to use clinical observations to generate new discoveries in neuroscience.
The specific aim of this R13 proposal is to provide support for early career investigators for the
following activities:
● Career development sessions, including
○ Curated interactions with to more senior investigators;
○ A panel discussion on diversity, equity, and inclusion in the computational
psychiatry field;
○ A career journey discussion.
● Two tutorials to allow researchers with limited expertise to broaden their
knowledge base; the tutorials are particularly important for this community
because this conference brings together researchers from two very separate
expertises (computational neuroscience and clinical psychiatry).
● Poster awards for trainees.
● Travel support for early career investigators from communities underrepresented
in medicine and science.

Public health relevance
Project Narrative The purpose of this R13 conference grant is to seek partial funding for the second international Computational Psychiatry Conference. This meeting will bring together a diverse array of junior and senior investigators working on both clinical and computational questions related to mental health, including addiction. A successful second meeting will help ensure that this conference becomes a productive and career-enhancing annual event for researchers in this new field to translate neuroscience discoveries into psychiatric clinical practice and to use clinical observations to generate new discoveries in neuroscience.